Molecular mechanism of hypoxia sensing by HIF hydroxylases

? DESCRIPTION (provided by applicant): Prolyl hydroxylase (PHD2) and `factor inhibiting HIF' (FIH) are the primary O2-sensors in human cells. PHD2 and FIH are Fe(II)- αKG-dependent dioxygenases, catalyzing the oxidative decarboxylation of αKG to produce succinate and CO2 to generate a ferryl oxidant, which hydroxylates specific amino acid residues on the hypoxia inducible factor (HIF) - PHD2 and FIH turn off HIF-controlled gene expression in response to increases in [O2]. The key to sensing O2 is to ensure that O2 activation only occurs after the substrate (HIF) binds to the enzyme. Contacts involved in substrate-triggered O2-activation are poorly understood for the HIF hydroxylases, as well as for the broader class of αKG-dependent dioxygenases, yet are key to O2-sensing by HIF hydroxylases. The central hypothesis of this proposal is that changes in the second coordination sphere are induced by substrate binding, and these changes increase the rate of ligand exchange, and the O2-affinity at the cofactor. We will test this model using steady-state kinetic probes coupled with electronic spectroscopy and crystallography to correlate reactivity with Fe(II) geometry. These mechanistic studies will increase our understanding of O2 activation by the broader class of αKG oxygenases, as well as providing specific insight into the reactivity of the HIF hydroxylases. We will extend this understanding into engineering of FIH to perform radical rebound chemistry leading to new C-X bond forming reactions.

Public health relevance
PUBLIC HEALTH RELEVANCE: HIF hydroxylases are the primary O2-sensors in human cells, acting to control O2-homeostasis through the hypoxia-inducible factor (HIF). HIF controls over 100 genes involved in anaerobic metabolism, angiogenesis, and erythropoiesis, which are crucial for lung development, inflammation, and vascular remodeling. This research will provide molecular-level insight into functionally important parts of the HIF hydroxylases, and may provide a guide to design future therapeutics for ischemia, lung disease, or cancer.